Romosozumab as an adjunct to physiologic estrogen replacement in adolescents and young adults with functional hypothalamic amenorrhea

Abstract
Low bone mass is a major co-morbid complication of functional hypothalamic amenorrhea (FHA) in adolescents
and young adult women, including those with anorexia nervosa (AN) and exercise-induced amenorrhea (EIA).
We propose to test in an 12-month randomized controlled trial the hypothesis that administration of
romosozumab (vs. placebo) for 6 doses monthly followed by a single dose of zoledronic acid to amenorrheic
adolescents and young women with FHA receiving transdermal estradiol replacement (with cyclic progesterone)
and calcium and vitamin D supplementation who have not yet achieved peak bone mass will result in bone
accrual that exceeds that of normal-weight controls without FHA with the potential to normalize bone endpoints.
84 participants with FHA will be randomized in a 2:1 ratio in a double-blind fashion to romosozumab or identical
placebo injections monthly for 6 injections, to determine effects on bone mineral density (BMD), markers of bone
metabolism, and bone geometry and bone strength at various skeletal sites using dual energy x-ray
absorptiometry (DXA), high resolution peripheral quantitative computed tomography (HRpQCT) and microfinite
element analysis (µFEA). This will be followed in all FHA subjects by a single zoledronic acid intravenous (IV)
infusion at 6 months to consolidate gains from romosozumab therapy. All participants with FHA will also receive
a 100 mcg transdermal estradiol patch (twice weekly) applied continuously, and 200 mg of oral micronized
progesterone for the first 12 days of each month, which are known to improve, but not normalize, bone outcomes
in FHA. In addition, 30 healthy controls will be followed prospectively for 12 months. All participants with FHA
and healthy controls will receive at least 800 IU of vitamin D and 1000 mg of calcium daily (RDA) to avoid effects
of suboptimal vitamin D concentrations on bone. There will be a one-month visit to determine whether
romosozumab exerts the expected acute osteoanabolic effects in the FHA group vs. placebo, as studies have
shown that the maximal anabolic effect of romosozumab is within the first month. We will determine whether
romosozumab increases areal BMD (by DXA) and improves bone geometry (assessed by HRpQCT) and bone
strength (assessed by microfinite element analysis) at 6 months in the FHA group compared with placebo. We
will also compare the romosozumab group to healthy controls to determine whether the rate of improvement in
bone endpoints exceeds that of healthy controls, resulting in catch-up and providing the anabolic boost
necessary to set individuals with FHA on the path to normalization of bone endpoints. Moreover, we will
determine whether 6 months of romosozumab followed by one IV zoledronic acid infusion improves BMD, bone
geometry, and strength at 12 months in girls and women with FHA more than placebo followed by zoledronic
acid and at a greater rate than in normal controls.

Public health relevance
Narrative Teenagers and young adult women whose menstrual periods cease due to restrictive eating disorders, such as anorexia nervosa, and/or from excessive exercise, have low bone density and increased fracture risk. This double-blind, placebo-controlled study will examine whether administration of a medication (romosozumab) for 6 months that increases bone formation and reduces bone breakdown, followed by a single dose of an additional medication (zoledronate) to extend the effects of romosozumab will provide a necessary boost to allow bone health to normalize in teenagers and young adult women with these disorders who are also receiving estrogen replacement.